Candida albicans phenotypic switching: Transcriptional regulation and virulence attributes

PROJECT SUMMARY/ABSTRACT
Candida albicans is the number one cause of life-threatening fungal infections in hospitals. A key virulence
attribute of C. albicans is the ability to switch between multiple distinct cellular forms that are adapted to unique
environmental niches. Heritable yet reversible differentiation between “white” and “opaque” cell types generates
two distinct pathogenic forms of C. albicans derived from a single genome, with differential expression of nearly
one in five genes in the organism. Most virulence studies in C. albicans have focused on the white cell type since
most strains were believed to be incapable of switching to the opaque state without first undergoing chromosomal
rearrangements; however, this assumption has recently been shown to be untrue. Although opaque cells have
long been known to be far more adept at infecting skin than white cells, very little is known about the unique
virulence attributes of the opaque cell type, or how stochastic switching between the white and opaque cell types
contributes to the progression of an infection. Instead, our understanding of the white-opaque switch has largely
focused on the transcriptional regulatory network that controls the heritable differentiation between these two
cell types. This network bears a striking resemblance to similar networks that control cellular differentiation in
higher eukaryotes; however, equivalent programs are not found in other model yeasts like Saccharomyces
cerevisiae or Schizosaccharomyces pombe, making C. albicans an attractive “simple” eukaryotic organism to
study how complex transcriptional programs are established and inherited from one generation to the next. We
propose to use a recently developed planarian model of infection, which reveals similar opaque-specific virulence
characteristics as the mouse skin model, to identify opaque-specific virulence genes. Combined with our recently
developed fluorescent switch-reporter strains, we will also investigate the yet unexplored contribution of
stochastic white-opaque switching to C. albicans virulence. These approaches are tailored to enable
undergraduate researchers to easily gain hands-on experience with animal models of fungal pathogenesis and
contribute to our understanding of an understudied aspect of C. albicans virulence while simultaneously avoiding
the high cost and added complications of vertebrate animal models. We have also found that Wor1, the master
regulator of the opaque cell type, forms large macromolecular condensates in the nuclei of opaque cells, and we
propose to use ultra-high resolution fluorescence imaging combined with molecular genetics approaches to
characterize these protein condensates and determine their role in the establishment and heritable maintenance
of the opaque cell type. Together these approaches will provide novel insights into the transcriptional regulatory
control of stochastic white-opaque switching, identify opaque-specific virulence genes, and inform how switching
between these two differentiated cell types contributes to epithelial adhesion and damage, and progression to
invasive candidiasis.

Public health relevance
PROJECT NARRATIVE Candida albicans is among the most common fungal pathogens of humans, causing debilitating and life- threatening infections, especially in immunocompromised individuals. C. albicans can switch reversibly between two distinct pathogenic cell types – white and opaque – however the genes that underlie the unique virulence attributes of the opaque cell type are largely unknown and fundamental questions remain regarding the molecular mechanisms that govern switching between these two cell types. This proposal seeks to understand the role of white-opaque switching in C. albicans virulence and to uncover fundamental mechanisms that enable the heritable maintenance of the opaque cell type across hundreds of generations.